Advancing ribosome-targeting antibacterial peptides with a unique mechanism of action

Project Summary
Apidaecin (Api) and Drosocin (Dro), are proline-rich antimicrobial peptides (PrAMPs) produced by honeybees and
fruit flies, respectively, which share a unique mechanism of action. Our previous studies of Api showed that upon entering
Gram-negative bacterial cells through the SbmA transporter, Api binds in the exit tunnel of ribosomes that have just released
the newly made protein and arrests the ribosomes at stop codons by trapping the associated tRNA and release factor. As
such, Api represents the first-ever described specific inhibitor of translation termination. Our subsequent whole-genome
studies revealed that arresting terminating ribosomes triggers several downstream events that accentuate the inhibitory
action of this PrAMP, including ribosome queuing and readthrough of stop codons. Our preliminary data indicate that Dro,
despite its distinct amino acid sequence, inhibits the termination step of translation as well, by a mechanism likely resembling
that of Api. Their idiosyncratic mode of binding to the target, the unique mechanism of action, and the triggering of
downstream effects harmful for the bacterial cell, make these antibacterial peptides an attractive model for developing novel
antibiotics. Furthermore, the biological nature of these PrAMPs opens unique opportunities for their screening and
optimization by generating hundreds of thousands of peptide variants directly in bacterial cells.
In the current proposal we will use the combined effort of three laboratories with expertise in biochemistry and
genomics of ribosomal antibiotics, in peptide chemistry and in structural analysis of ribosome-antibiotic complexes to
advance the fundamental understanding of the mechanism of action of Api- and Dro-like translation termination inhibitors
and identify derivatives with superior on-target activity and expanded spectrum of antibacterial action. In order to achieve
these goals we will test arrays of Api and Dro variants in bacterial cells by the tunable expression of peptide gene libraries,
determine high-resolution X-ray crystal structures of ribosome-peptide complexes, and employ rational structure-based
design to generate via chemical synthesis peptide variants with superior properties. Specifically: In Aim 1, we will identify
Api-derived peptides with improved activity upon ribosomes from Gram-negative and Gram-positive pathogens. In Aim 2,
the spectrum of action of Api-like peptides will be expanded by bypassing the necessity for uptake by the SbmA transporter.
Finally, in Aim 3, we will analyze the ribosome binding and mechanism of action of Dro-like peptides and use comparative
analysis to identify the key features that define the class of antimicrobial peptides that target translation termination. The
three Aims are tightly interconnected but completely independent from each other.
The reagents and tools that will be generated in the course of the proposed work are aimed to serve as leads for
future clinical development. Importantly, the results obtained in the proposed studies will significantly advance the
fundamental understanding of the properties and mechanisms of action of PrAMPs and will stimulate the progress of the
field of ribosome-targeting antibacterial peptides, which currently is still in its infancy.

Public health relevance
Narrative Apidaecin and Drosocin are antibacterial peptides produced by honeybees and fruit flies, respectively. They stop the growth of bacteria by exploiting a unique mechanism - inhibiting the termination step of protein synthesis. However, these antibiotics are active only against several bacterial species and many aspects of their action remain unknown. In the proposed project, we will expand the understanding of how this class of antibacterials achieve their inhibitory action on bacteria. We will expand the variety of antibacterial peptides that affect protein synthesis termination and broaden the spectrum of action of these unique antibiotics.